Mechanisms of Disease and Translational Science

Abstract/Project Summary
Accelerating the translation of fundamental scientific discoveries into tangible advancements in
human health stands as a foremost national priority. Regrettably, conventional graduate education in
biomedical sciences primarily emphasizes didactic knowledge and hands-on research experience.
Insufficient emphasis is placed on cultivating the skillset required to propel basic scientific
breakthroughs from the laboratory to practical applications at the patient's bedside. Furthermore,
once students complete their graduate studies, the opportunities to formally acquire the indispensable
knowledge for conducting and propelling translational research become even scarcer. The UT
Southwestern Medical Center's Mechanisms of Disease and Translational Science program (MoDTS)
was created as a supplementary graduate student track to complement the traditional training
regimen for PhD candidates and to close the gap between basic and translational research training.
The MoDTS initiative pairs PhD candidates with qualified, passionate clinical preceptors
specializing in medical fields pertinent to the student's thesis. The overarching aim revolves around
acquainting students with clinical practices and fostering connections that facilitate translational
research endeavors. The program initiates in the third year of graduate school and continues until
graduation. It encompasses a series of obligatory and elective avenues, including continuous clinical
shadowing, medical-student level courses, seminars, nanocourses, and internships. Trainees
committed to translational research will be funded for one-year periods to facilitate clinical
collaborations and experiential learning opportunities. These avenues provide atypical yet invaluable
instruction across an array of subjects, such as crafting IRB protocols, technology transfer and
development, patent procedures, and the design and execution of clinical trials.
We are requesting 8 positions to allow trainees to commit to extracurricular, translational training,
including experiential training and internships. Most trainees will be appointed for one year, however
second and even third years of support will be provided under exceptional situations. Ultimately, our
program's objective centers on furnishing PhD candidates with the proficiencies requisite for
propelling fundamental scientific discoveries out of the laboratory and into the hands of healthcare
providers. Our expected outcomes are to train students to be actively involved in translational
research through a variety of career options.

Public health relevance
Program Narrative Translating basic science discoveries into products that improve human health is a priority for the NIH. Most PhD programs do not provide training/education to facilitate this goal. The Mechanisms of Disease and Translational Science track at UTSW provides supplemental training for PhD candidates to introduce them to the processes and skills required to move basic science discoveries from the bench to the bedside.